Preclinical Efficacy and Safety Core

PROJECT SUMMARY/ABSTRACT PRECLINICAL EFFICACY AND SAFETY CORE
The PRECISION-AD Preclinical Efficacy and Safety (PE&S) Core will serve three key functions: 1) optimize
automated methods for scaling iPSC-derived 2D and 3D cultures to enable testing of interventions across genetic
backgrounds; 2) implement automated assays to test candidate therapeutic interventions for AD across 100
genetic backgrounds; and 3) establish robust and efficient pipelines for sharing protocols and cellular models
developed under this award. In order to accomplish these goals, the PE&S will work closely with the MPS Core
to adapt their assays and protocols for automation. The work proposed under this core is made possible by
NYSCF’s fully robotic platform (the NYSCF Global Stem Cell Array, GSCA)1 that automates iPSC derivation,
differentiation, gene editing, high-content imaging, and drug screening to enable population-scale stem cell
disease modeling and high-throughput drug discovery. Using this robotic platform, this core will scale both 2D
and 3D microphysiological systems (MPS) to enable the testing of therapeutic interventions across 100 genetic
backgrounds. Across these genetic backgrounds, the PE&S core will measure a panel of biomarkers identified
by the BCB and MPS core that reflect responsiveness to each intervention tested. In addition, the core will
establish and implement robust assays of cell health and cell type proportions using high throughput imaging
and automated analysis pipelines. This core will develop rigorous best practices for testing of efficacy and toxicity
in both 2D and 3D MPS and establish a core set of reporting standards and protocols for interrogating person-
specific or subtype-specific responses to treatments. This work will be shared with the scientific community
through efforts within the ADM Core including the development of online resources allowing the dissemination
of protocols, data and cell line availability.